FFA Metabolism in Different Types of Human Obesity

Project Summary/Abstract
Our goal is to understand the mechanisms by which obesity, and specifically upper body/visceral
obesity (UBO), causes insulin resistance, Type 2 Diabetes and the other health problems. We study what
regulates the release of free fatty acids (FFA) from adipose tissue (lipolysis) in humans. For this application we
propose to complete the following Specific Aims: 1. We will determine whether impaired insulin-induced
suppression of regional lipolysis (measured by IC50) in UBO compared with insulin-sensitive control groups is
related to differences in adipocyte lipolysis protein responses. 2. We will determine whether the suppression of
regional lipolysis induced by niacin, acting independently of the insulin signaling pathway, is impaired in UBO
compared with insulin-sensitive control groups and, if so, if this is related to local differences in adipocyte
lipolysis-regulating proteins. 3. We will determine whether stimulated adipose tissue lipolysis resulting from the
combination of somatostatin infusion (to suppress insulin secretion) and intravenous epinephrine, is impaired
in UBO compared with insulin-sensitive control groups and, if so, if this is related to regional differences in
lipolysis and adipocyte lipolysis-regulating proteins. 4. We will determine whether the regional release of FFA
relative to glycerol as a measure of intracellular reesterification accounts for the differences in systemic FFA
delivery between UBO and non-UBO adults. Combined, we believe these studies will offer insights as to
whether adipose tissue lipolysis is abnormal in UBO specifically in response to insulin, or if there are more
fundamental issue with metabolic flexibility that relate to adipocyte size. By understanding what is different in
the process of lipolysis in UBO we hope to provide guidance as to what therapeutic strategies might be
employed to treat adipose dysfunction.

Public health relevance
Project Narrative We wish to understand why people who gain excess weight in the abdomen are more prone to diabetes and high blood fats. The fat tissue under the skin in the abdominal area releases excess fat into the bloodstream, which effects how the rest of our body can metabolize sugars. We are proposing experiments that will measure whether fat cells in leg and abdominal fat are regulated differently in people with excess abdominal fat, and whether this is due to altered functions of certain proteins inside the fat cells.